Intrinsic Inhibitory Mechanisms of Vagal Nociceptors

Project Summary/Abstract
In visceral inflammatory disorders the excitability and activation of visceral nociceptive sensory nerves are
abnormally enhanced, contributing to the difficult-to-treat clinical symptoms such as visceral pain and
discomfort, bladder irritability, diarrhea/constipation, cardiac arrhythmias, bronchospasm, heartburn, dyspnea,
and unproductive coughing. The pathogenesis of visceral nociceptor sensitization is complex and poorly
understood. Our long-term objectives are to elucidate the ionic/molecular mechanisms underlying the
regulation and dysregulation of visceral nociceptor excitability, and to identify novel therapeutic strategies
aimed at reducing the suffering of the millions afflicted with chronic visceral diseases. The excitability of
neurons, including visceral nociceptors, is dynamically regulated by concerted action of excitatory and
inhibitory ion channels. The last few decades of intensive research in visceral nociceptive nerves has mainly
focused on various excitatory ion channels while much less is known about the K+ channels that exert
inhibitory control on nociceptor excitability. Our recently published work and new preliminary data are revealing
that among the plethora of functionally diverse voltage-gated potassium (KV) channels two subtypes, the
KV7/M-type (IM) and KV1/D-type (ID) K+ channels, mediate the majority of sustained inhibitory K+ currents at the
subthreshold voltages, thereby playing the critical role of "braking" the activation in vagal visceral nociceptors.
We therefore hypothesize that inhibition in activity and/or expression of KV7/IM or KV1/ID channels in vagal
nociceptors leads to vagal visceral nociceptor sensitization and thus contributes to exaggerated visceral
nociceptive reflex responses, and that selective pharmacological activation of "braking" K+ channels may
provide novel therapeutic strategies for the management of debilitating neurological symptoms associated with
various visceral disorders. Our four specific aims are designed to address these hypotheses by investigating
the consequences of genetic inactivation and pharmacological activation of KV7/IM and KV1/ID channels on the
excitability of the vagal visceral nociceptive nerves at the levels of cell bodies, nerve terminals as well as
defensive reflex behaviors, and by investigating the effects of visceral inflammation on the expression and
function of these channels in vagal nociceptors. To achieve these aims, we will use the most up-to-date
innovative technologies, including single-cell RNA sequencing, state-of-the-art patch clamp techniques, two-
photon microscopic calcium imaging and extracellular electrophysiological recording of single fiber activities,
and respiratory reflex measurement in awake mice, combined with sensory neuron- and nodose neuron-
specific gene knock-out and knock-down strategies. By pursuing the proposed study, we will advance our
knowledge about the ion channel mechanisms underlying the vagal nociceptor sensitization associated with
inflammatory diseases, and identify the braking K+ channels as promising novel therapeutic targets to quell the
abnormal visceral nociceptive responses in diseases.

Public health relevance
Narrative Heightened activation of visceral nociceptive sensory nerves in visceral inflammatory disorders contributes to the difficult-to-treat clinical symptoms including among others, visceral pain, bladder irritability, diarrhea/constipation, cardiac arrythmias, bronchospasm, heartburn, nonproductive coughing, sensations of breathlessness. The long-range goal of this proposal is to develop a better understanding of the mechanisms that regulate the activity of these visceral sensory nerves and to identify therapeutic strategies aimed at limiting their aberrant activation and as such, reducing the suffering of the millions afflicted with various visceral inflammatory diseases.